Smooth Muscle Mineralocorticoid Receptor in Obesity-Induced Vascular Stiffness

Obesity impacts 42% of US adults with greater prevalence in women. Obesity is associated with increased risk
of cardiovascular (CV) disease. Elevated body mass index strongly correlates with large vessel vascular stiffness
which increases cardiac work and damages small vessels, thereby also correlating with risk of hypertension,
heart attack, stroke and heart failure. The associations of obesity and vascular stiffness with adverse CV
outcomes are steeper in woman than men, suggesting sex-specific mechanisms that may require precision
targeting strategies. This competitive renewal application proposes to explore the role of the mineralocorticoid
receptor (MR) in vascular smooth muscle cells (SMC) in sex-specific mechanisms of obesity-induced vascular
stiffness. The MR is the aldosterone-activated transcription factor that regulates blood pressure in the kidney.
Our published data from the prior cycle implicated SMC-MR in vascular aging. Our new preliminary data reveals
that SMC-MR expression is increased in the aorta of obese versus lean mice and in primary human aortic
(HA)SMCs from obese vs lean human donors. We also show that mice with SMC-specific MR deletion (SMC-
MR-KO) are protected from high fat diet (HFD)-induced aortic stiffening in both sexes, but by sexually dimorphic
mechanisms. This proposal tests the hypothesis that obesity causes perivascular adipose tissue (PVAT)-derived
oxidative stress in females whichinduces SMC HIF1α and the MR-1α isoform while in males, PVAT inflammation
predominates and induces SMC NFκB raising both MR isoforms, and that these sexually dimorphic mechanisms
drive global sex-specific changes in vascular stiffness genes resulting in vascular stiffening and cardiac
dysfunction in obesity. Using innovative approaches including a novel mouse with CRISPR/Cas9-mediated
knock-in of an HA tag in the MR genomic locus, a mouse with SMC-specific inducible oxidative stress, spatial
transcriptomics of single mouse aortas with perivascular adipose tissue (PVAT) combined this ChIP-sequencing,
multiplexed RNA-FISH, and atomic force microscopy (AFM) combined with confocal microscopy, we propose 3
Aims: SA1-Determine sex-specific mechanisms bywhich MR is induced in SMC by obesity; SA2-Identify sexually
dimorphic mechanisms of obesity-induced vascular stiffening and its impact on CV function; and SA3-Explore
sex-specific, SMC-MR-dependent mechanisms controlling global aortic gene expression in obesity. Each aim
uses primary human aortic SMCs from lean males and females (BMI<=25) to those with obesity (BMI>=30) and
male and female mouse models with diet-induced obesity. Completion of the aims will determine novel sex-
specific mechanisms driving obesity-associated vascular stiffness and end organ dysfunction, implicating SMC-
MR by using innovative approaches. The long-term goal is to determine sex-specific precision medicine
strategies, including FDA approved MR antagonists, to mitigate obesity-induced vascular stiffening and the
myriad of adverse consequences in order to ameliorate the expected rise in CV disease as the growing obese
population ages.

Public health relevance
Project Narrative: Almost half the US population is obese, which causes stiffer blood vessels, and contributes to a high risk of high blood pressure, heart attack and heart failure. The negative impact of obesity and of blood vessel stiffening on heart health is more significant in women. This proposal will advance our understanding of how obesity causes blood vessel stiffness differently in males versus females and implicates the mineralocorticoid receptor in the process, for which we have approved medications that could prevent the adverse cardiovascular effects of obesity, especially in women.